NIH Project 5 COVID-19 Data Hub - CDEs and Common Data Model

Office of Data Science Strategy (ODSS) agrees to provide $150,000.00 to the National Cancer Institute to support NIH Project 5 COVID-19 Data Hub - CDEs and Common Data Model.